Fatty Acid Defects & Oxidative Stress Modulate Islet Function in Cystic Fibrosis

DESCRIPTION (provided by applicant): Cystic fibrosis related diabetes (CFRD) is one of the most significant co-morbidities in Cystic Fibrosis (CF), affecting almost half of patients over 30 years of age. CFRD is associated with a high morbidity and mortality. Insulin secretory defects are inherent to CF, with diminished and/or delayed insulin responses to oral glucose demonstrated in CF patients both with and without diabetes. Because the islet mass is generally retained in CF, therapies to restore insulin secretion will significantly reduce the incidence of CFRD and thus morbidity and mortality. However, there are no such therapies, because the mechanisms underlying kinetically altered insulin secretion in CF are not known. Oxidative stress and fatty acid perturbations have well-established roles in the pathophysiology of lung disease in CF and type 2 diabetes mellitus, but have not been studied in CFRD. Cystic fibrosis transmembrane conductance regulator (CFTR)-knockout pig and ferret models developed at the University of Iowa have multi-organ disease similar to humans with CF. However, the evolution to CFRD and its severity are different between the two models. At birth, both models have abnormal insulin secretion, but the concomitant exocrine pancreatic disease is mild in CF ferrets and advanced in CF pigs. Pancreatic disease advances rapidly in CF ferrets after birth and they develop progressive hyperglycemia, whereas the pancreatic disease progression is slower in CF pigs and they do not develop hyperglycemia as adults. At birth, CF pigs and ferrets have an imbalance of polyunsaturated fatty acids (PUFA) similar to patients with CF and have markers of pancreatic oxidative stress. Given their varying degrees of exocrine pancreatic disease at birth, divergent evolution to CFRD, fatty acid alterations similar to CF humans and pancreatic oxidative stress, CF ferret and porcine models provide unique and complementary opportunities to investigate the pathogenesis of insulin secretion defects in CF. We hypothesize that the oxidative stress and CF-related PUFA imbalance are key mechanisms that underlie the impaired insulin secretion in CF. We will test this hypothesis in both CF pig and ferret models with the following specific aims: (1) Determine the effect of reactive oxygen species (ROS) and oxidative stress on insulin secretion in vivo by the CF pancreas; (2) Determine the effect of CF-related PUFA imbalance on insulin secretion in vivo by the CF pancreas; (3) Determine the effect of fatty acid alterations and ROS on insulin secretion by isolated islets. The first aim wil determine the relationship between increased levels of ROS, oxidative stress, and antioxidant capacity in CF pig and ferret pancreas along with correlating the severity of redox changes with insulin secretion. The second aim will determine whether correcting CF-related PUFA imbalance will restore the !-cell function in CF pancreas. The third aim will ! examine the extent to which the fatty acid alterations and oxidative stress are intrinsic mechanisms of impaired insulin secretion in CF islets. The objective of this application is to identify oxidative stress and CF-related PUFA imbalance as key pathways in the pathogenesis of CFRD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cystic fibrosis related diabetes (CFRD) is the most common comorbidity in Cystic Fibrosis (CF) and it is associated with increased mortality and rapid decline in lung function. The objective of this proposal is to examine the role of oxidative stress and CF-related polyunsaturated fatty acid (PUFA) imbalance in the pathogenesis of CFRD. The long-term goal is to develop improved therapies to prevent the insulin secretory defects in CF and the progression to CFRD. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Cystic fibrosis (CF) is the most common life threatening recessive genetic disorder in Caucasians. It is caused by mutations in the gene that encodes cystic fibrosis transmembrane conductance regulator (CFTR). The exocrine pancreas is involved early and universally in CF disease processes, but patients generally die of pulmonary complications. Cystic fibrosis related diabetes (CFRD) is one of the most significant co-morbidities, affecting ~50% of CF patients >30 years of age. CFRD is associated with a rapid decline in pulmonary function, higher morbidity and greater mortality. Insulin secretory defects are inherent to CF, with diminished and/or delayed insulin responses to oral glucose demonstrated in CF patients both with and without diabetes. Because islet mass is generally retained in CF, therapies to restore insulin secretion will significantly reduce the incidence of CFRD and thus morbidity and mortality. However, there are no such targeted therapies, because the mechanisms underlying kinetically altered and generally impaired insulin secretion in CF are not known. The overall hypothesis of this proposal is that oxidative stress and CF-related polyunsaturated fatty acid (PUFA) imbalance are key pathways that alter insulin secretion in CF. These two mechanisms have well- established roles in the pathophysiology of lung disease in CF and etiology of type 2 diabetes mellitus, but have not been studied in CFRD. The CFTR-knockout pig and ferret are ideal CF models that develop multi- organ disease similar to human CF patients. However, the evolution to CFRD and its severity are different between the two models. At birth, both models have impaired first phase insulin secretion, but the concomitant exocrine pancreatic disease is mild in CF ferrets and substantial in CF pigs. The pancreatic disease advances rapidly in CF ferrets after birth and they develop progressive hyperglycemia, whereas CF pigs have yet to develop hyperglycemia despite insulin abnormalities in the newborn period. At birth, both CF pigs and ferrets have an imbalance of PUFA similar to patients with CF (low linoleic acid (18:2!-6), low docosahexaenoic acid (DHA, 22:6!-3), high eicosatrienoic acid (20:3!-9)) and have markers of pancreatic oxidative stress. Given their varying degrees of exocrine pancreatic disease at birth, divergent evolution to CFRD, fatty acid alterations similar to CF humans and pancreatic oxidative stress, CF ferret and porcine models provide unique and complementary opportunities to investigate the pathogenesis of insulin secretion defects in CF. With the long term aim of identifying CFRD preventive strategies, we propose to study the role of oxidative stress and PUFA imbalance on CFTR-dependent processes, both extrinsic and intrinsic to the islet, in the development of early insulin secretory abnormalities in CF pigs and ferrets with the following specific aims: Aim 1: Determine the effect of reactive oxygen species (ROS) and oxidative stress on insulin secretion in vivo by the CF pancreas. Hypothesis: Pancreatic ROS and oxidative stress alter insulin secretion from the CF pancreas in vivo. This aim will examine the relationship between increased levels of ROS, oxidative stress, and antioxidant capacity in CF pig and ferret pancreas along with correlating the severity of redox changes with insulin secretion in response to glucose and L-arginine challenge. We will examine the impact of prenatal and postnatal supplementation with thiols (given as N-acetylcysteine, NAC) or apocynin (a NADPH oxidase-2 inhibitor) on reducing pancreatic oxidative stress, normalizing glucose- and L-arginine-dependent secretion of insulin (CF pigs and ferrets) and slowing the progression to hyperglycemia (CF ferrets). Aim 2: Determine the effect of CF-related PUFA imbalance on insulin secretion in vivo by the CF pancreas. Hypothesis: CF-related PUFA imbalance impairs insulin secretion from the CF pancreas in vivo. This aim will determine whether correcting CF-related PUFA imbalance will restore the "-cell function in CF pancreas. We will supplement linoleic acid and/or DHA to CFTR+/! pregnant jills and sows and assess whether this will normalize first phase insulin secretion in CF pigs and ferrets at birth. Non-CF littermates will serve as matched controls. Linoleic acid- and DHA-supplementation will be given to newborn kits for 2 months to evaluate whether progressive "-cell failure and hyperglycemia can be prevented in CF animals by restoring PUFA balance. Aim 3: Determine the effect of fatty acid alterations and ROS on insulin secretion by isolated islets. Hypothesis: CF-related PUFA imbalance and oxidative stress directly inhibit the first phase insulin secretion by islets. This aim will determine the extent to which the fatty acid alterations and oxidative stress are intrinsic mechanisms of impaired insulin secretion in CF islets. Non-CF and CF islets will be exposed to the CF-related PUFA imbalanced or PUFA-supplemented media to determine the impact and CFTR-dependence of PUFA on insulin secretion by the islet. The impact of CFTR on islet GSH transport and antioxidant reserves will determine if CF islets are more prone to ROS-induced cell death, apoptosis, and oxidative stress that can alter insulin secretion. The effects of GSH or apocynin on reducing the oxidative stress and normalizing insulin secretion in CF islets will be studied. The novel porcine and ferret CF models offer a unique and complementary opportunity to evaluate the role of oxidative stress and fatty acid alterations on insulin secretory defects of CF. Importantly, these pathogenic mechanisms of CFRD are potentially amenable to existing interventions.